Multidisciplinary approach to study of patients with Severe Alcoholic Hepatitis Undergoing Liver Transplantation

Project Summary
Alcoholic liver disease (ALD) is among the most common indications for liver transplant (LT), accounting for
over 30% of LTs performed annually in the United States. Given concerns for post‐transplant recidivism,
transplant centers have required 6 months of documented sobriety prior to LT. However, a subset of patients
present for medical care with severe alcoholic hepatitis (SAH), requiring urgent and aggressive medical
management. If they are unresponsive to medical treatment, LT is the only life‐saving option. Without LT, SAH
patients have a 70‐80% three‐month mortality, therefore a 6‐month sobriety rule precludes most patients from
life‐saving LT. We have demonstrated that early LT (ELT) for SAH provides excellent short‐term survival
and similar recidivism rates in comparison to LT for ALD with 6 months sobriety.
ELT for SAH is rare and controversial, because at many centers, the standard 6‐month sobriety period
is a transplant candidacy requirement. However, critics of this requirement emphasize that an unreliable
predictor of recidivism. In order to minimize risk to the public perception, careful analysis of ELT selection
criteria is crucial to ensure allocation to those with the greatest survival benefit and highest chance of
maintained sobriety. Ethically sound candidate selection criteria is paramount to identifying SAH patients who
would significantly benefit from ELT.
In this study we will identify social determinants of health (SDoH) affecting access to ELT and assess how
SDoH impact short- as well as long-term outcomes in ELT. We will also determine the ethical issues
surrounding the practice by evaluating stakeholder opinions regarding ELT for SAH, in an effort to develop a
comprehensive national policy. Further, we will examine recidivism in ELT recipients, comparing differing
behavioral and pharmacologic interventions to identify mitigating strategies. We will also continue the study of
explanted livers from patients undergoing transplant to identify the molecular-level changes characterizing the
pathophysiology of SAH. Lastly, we seek to utilize small animal models of liver transplantation in conjunction
with alcohol exposure to answer questions about liver regeneration, and the immune system that cannot be
answered directly from our patients. This work is now being conducted under the auspices of our “DELTA
Center” (Delivery of Early Liver Transplant for Alcoholic Hepatitis) at Johns Hopkins.
The identification of SDoH that affect access to ELT for will provide actionable areas for improving delivery of
this service to the most disadvantaged of an already vulnerable population. The ethical insight from
stakeholders will aid in the development of a national policy for the practice, and insights gained from
investigation of post-transplant recidivism interventions, explant pathology, as well as animal models of SAH,
will provide us with a more comprehensive understanding of the disease pathophysiology and management.

Public health relevance
Project Narrative Severe alcoholic hepatitis (SAH), an acute presentation of alcoholic liver disease (ALD), carries an extremely high mortality rate and early liver transplantation (ELT) is the only life-saving option available for patients who are refractory to medical management. We have established the largest cohort of ELT recipients in the world and preliminary investigations have shown promising short-term outcomes for individuals who undergo ELT and given us considerable insight into the pathophysiology of ALD. The insight provided by the studies described in the projects that comprise our ALD research initiative will be integral for guiding the expansion of ELT and the ethical framework developed will help influence the creation of a national policy governing the practice.